Studying the Effects of Radiation and Systemic Inflammation on Microglia Contribution to Brain Metastasis Outgrowth

PROJECT SUMMARY
Brain metastasis is a complex process which involves the tumor cells, resident cells, and infiltrating immune
cells. Glial cells are long lived and have been shown to react to both radiation therapy and peripheral stimuli
such as systemic inflammation. Microglia can become continually reactive, inciting brain damage or creating a
prolonged inflammatory environment. As radiation therapy is oftentimes the first treatment option for patients
with brain metastasis, how glial cells and the broader niche responds, is critical to study. Various functions of
microglia including their ability to engage in complement signaling is fundamental to their proper functioning.
How radiation influences this pathway is not well understood. Furthermore, many people today have systemic
inflammation, which will also influence glial responsiveness to treatment and further cancer growth. An emerging
body of literature has demonstrated that non-adaptive immune cells have a form of ‘memory’ through epigenetic
regulation, which results in either an increased or decreased ability to react to subsequent stimuli. How the
systemic effect of inflammation, modeled by beta glucan, influences radiotherapy outcomes is not fully
understood. In the brain metastasis context, many peripheral immune cells will migrate to the brain. Ccr2 positive
myeloid cells increase proportionally in mice treated with radiation when compared to control mice. To gain a
better understanding of what is occurring within the treated brain metastatic niche this proposal seeks to examine
1) the mechanisms through which radiation therapy-stimulated complement signaling in microglia and infiltration
of peripheral myeloid cells regulate brain metastasis progression and 2) discover how systemic inflammation
influences radiotherapy outcomes and how systemic inflammation could be treated to ensure proper microglial
functioning. Utilizing cellular imaging, qPCR, and ATAC- and RNA-seq we will explore how microglial cells are
trained by radiation, systemic inflammation, and how this could be treated. To discover how proper functioning
of microglia is critical to positive outcomes we will use genetic knockouts. The overarching hypothesis is that
radiation alone and radiation within the context of systemic inflammation leads to alterations within microglia
which contribute to a pro-inflammatory and overactive phenotype. To test this hypothesis two specific aims will
be explored. Experiments under Aim 1 will 1) if complement signaling is a factor in brain metastasis outgrowth
and 2) uncover the role of Ccr2+ infiltrating myeloid cells within the brain metastatic niche. Aim 2 will focus on 1)
how systemic inflammation trains microglia, 2) if the mechanism behind training is PI3K-AKT, and 3) if we can
treat systemic inflammation trained microglia with drugs that work synergistically with radiotherapy. Collectively
these data will reveal mechanisms important to metastatic growth within mice exposed to radiation alone or
radiation in concert with systemic inflammation, focusing primarily on microglia. This research will have broad
implications for understanding what is occurring within the brain metastatic niche as well as for potential avenues
for therapeutic potential.

Public health relevance
PROJECT NARRATIVE Long-lived glial cells can be primed after systemic insult, epigenetically predisposing them to certain behaviors. This project will primarily investigate how microglia are epigenetically altered by radiotherapy and systemic inflammation to promote tumor metastasis and growth. A greater understanding of pathways that underlie microglia response to metastasis, radiation, and systemic inflammation will allow for further progress regarding clinically relevant treatments.